Experimental Integration, Design and Analysis Core

Summary: Experimental Integration, Design and Analysis Core
The Experimental Integration, Design, and Analysis (EIDA) Core is an essential component of the program
project that is uniquely designed to implement novel cellular, molecular and informatic strategies, and to
synergize collaboration and integration of Program investigation to drive scientific discoveries. The Program is
thematically centered on novel mechanisms of epigenetic regulation that are relevant to breast cancer. The EIDA
Core is designed to capture the momentum of the Program, as well as to provide cohesive experimental and
analytical design that will ensure rigor and reproducibility. The EIDA Core will centralize experimental design,
bioinformatics support for data sharing and integration, and biostatistical analyses for patient-based, cell- and
organoid-derived findings. The Core will ensure that every project is using standardized reagents, protocols and
bioinformatics methods, such that data comparisons among projects can be made. Each project uses cutting-
edge omics-based approaches; the application of these technologies necessitates significant expertise and
implementation of best practices for scientific rigor and transparency, which will be provided by the EIDA Core.
Support by the Core is essential for discoveries that will be generated by each of the projects.
The goal of the EIDA core is to maximize integration of experimental effort and output. This innovative multi-
dimensional core will accelerate research progress of the Program. The Aims of the EIDA Core are to provide:
1) Generation and authentication of biological models and reagents. Stringent quality control of reagents and
uniform experimental protocols are essential for data comparison across all projects. 2) Analyses and integration
of next generation sequencing data will assure that multiple types of genomic data can be compared for
biologically relevant interpretation. Centralization of bioinformatics analysis in the Core positions the Program
bioinformatician to perform analyses with the overall Program strategy and goals in mind, so that data generated
by each Project can be used to inform and integrate results with the other projects. 3) Rigor and reproducibility
of experimental strategies through statistical validation of the findings will enhance and strengthen discoveries
that can be translated to clinical care in future studies.
Impact: The EIDA core will enable integration of datasets by connecting the shared and distinct properties of
epigenetic control and genome organization with breast cancer onset, progression and treatment response.

Public health relevance
NARRATIVE Experimental Integration, Design and Analysis Core The Experimental Integration, Design, and Analysis (EIDA) Core is innovatively designed to support Program Project investigations of different parameters of epigenetic control and genome organization that characterize breast cancer. The EIDA Core provides expertise in experimental design, data analysis, and laboratory support that will enhance scientific capabilities, integration, rigor and reproducibility of the Program. The Core will provide a centralized knowledge base to facilitate collaboration and data sharing to advance understanding of breast cancer biology and pathology.